Imaging and Response Assessment Core

THIS COMPONENT IS ENTITLED THE IMAGING AND RESPONSE ASSESSMENT CORE ABSTRACT Project Summary/Abstract The Imaging and Response Assessment Core (IRAC) is a shared resource that facilitates the use of both standard and novel imaging methods for characterizing tumor biology and predicting and monitoring response to therapy in clinical trials performed at the Siteman Cancer Center (SCC). To accomplish this, the IRAC provides a variety of services to investigators including: 1) assistance with protocol development; 2) imaging- related regulatory services; 3) site-qualification; 4) coordination of imaging examinations to ensure protocol compliance; 5) data transfer to trial sponsors or external core laboratories; and 5) tumor measurements on both anatomical and functional imaging studies performed by dedicated radiologists and nuclear medicine physicians. Additionally, the IRAC investigates new software tools to improve the accuracy and reproducibility of tumor measurements and to allow for incorporation of newer approaches of tumor measurement (for example, three-dimensional volumetric measurements and metabolic tumor volume) into clinical trials at SCC. The overall goal of IRAC is to increase the impact that quantitative imaging plays in clinical cancer research. The IRAC provides unique imaging management and analysis services that are not available elsewhere within Washington University. The SCC has a large portfolio of clinical trials that use computed tomography (CT), magnetic resonance imaging (MRI), and positron emission tomography (PET), and the IRAC contributes to the overall success of SCC trials by providing these services to investigators.

Public health relevance
THIS COMPONENT IS ENTITLED CORE PROJECT NARRATIVE Not applicable